Administrative Core

Core A – Project Summary/Abstract
Filoviruses are important emerging and biodefense pathogens with potential to impact global health. The
overarching goal of this renewal Program Project Grant (PPG) application is to characterize host-viral
interactions that contribute to filoviral infection, identify molecular interactions, and develop insights into
molecular mechanisms. This interdisciplinary project will provide insight into host interactions that drive filoviral
infections and identify new therapeutic targets. This multi-investigator collaborative effort will be conducted at
several sites and the Administrative Core (Core A) will provide administrative oversight and coordinate
interactions among sites to ensure that progress of this integrated research program will be maximized. Core
A will: 1. Coordinate communication by virtual meetings and teleconferences among the PIs of the Research
Projects and Scientific Cores, monthly web-based research-in-progress meetings, and an annual meeting
among members of all participating groups. These meetings will facilitate reagent and scientific exchange
among the different sites. 2. Coordinate annual meetings between the investigators and the External Advisory
Board (EAB) to assess scientific progress and to facilitate the distribution of critical evaluations on the
performance of the PPG. 3. Manage conflicts of interest and facilitate conflict resolution. 4. Coordinate fiscal
administration and Scientific Core usage to ensure that the research projects are well supported. 5. Facilitate
secure data sharing and access to inventory of reagents developed by Cores by implementing a cloud-based
commercial database platform. 6. Assist investigators with preparation and submission of annual progress
reports to the NIH and maintain a website for data dissemination. 7. Identify opportunities for training and
professional development for trainees within the PPG group and facilitate their participation and promote cross
training and expertise sharing. Through these collective actions, Core A will promote scientific interactions and
provide support for seamless functioning of the overall scientific mission to discover and characterize key host-
viral interactions that are critical for filoviral infections.